Ribosome stalling and activation of stress responses

PROJECT SUMMARY/ABSTRACT
During protein synthesis, the ribosome integrates multiple cues to ensure that the correct protein is made at the
right place, the right time and at the right concentration. These cues are the result of signals triggered by varying
cellular needs and environmental conditions such as proliferation and stress. In eukaryotes, the integrated-stress
response (ISR) responds to stresses through the activation of kinases that act on the initiation factor eIF2.
Phosphorylation of eIF2 represses global translation, but also derepresses translation of key pro-survival
mRNAs. In yeast, ISR is activated by the eIF2 kinase Gcn2. Recent studies from several groups, including
ours, have pointed to a central role for ribosomes and in particular their stalling during the activation of ISR.
Interestingly, ribosome stalling also activates ribosome-quality control (RQC), which depends critically on an E3
ligase Hel2. During the previous funding period, we established that Hel2 is activated in response to ribosome
collisions and showed that chemical insults that damage RNA trigger RQC. Notably, these very same agents
also activate ISR, suggesting that RQC and ISR are tightly be coordinated. In a very recent study, we showed
that not only do ribosome collisions activate both processes, but that the activation of one suppresses that of the
other. Emerging from these studies is the observation that collided ribosomes are widely used as sensors to
trigger an appropriate response, depending on the type and level of stress. Indeed, in preliminary data presented
in this proposal, we provide compelling evidence for a role for ribosome collisions in signaling to other nucleic
acid damage pathways, particular those involved in DNA-damage repair. This proposal is focused on
understanding the molecular rationale by which collided ribosomes can activate these seemingly unrelated
processes. Our preliminary data indicate that the A status of the ribosome is important for ISR activation, and in
Aim 1 we will probe the conformation of ribosomes under various stress conditions and assess how they impact
Gcn2 recruitment. We will expand on these studies by reconstituting ISR and RQC activities to provide a
mechanistic understanding for the apparent preferential activation of RQC over ISR. Notably, robust ISR also
requires the presence of the highly conserved transcriptional coactivator Mbf1, which we and others showed to
bind collided ribosomes. In Aim 2, we will test the hypothesis that stalling activates ISR using a two-pronged
mechanism, in which collided ribosomes in addition to activating Gcn2 modulate ISR coactivation by Mbf1. In
particular, we will dissect the role of Mbf1 interactions with the ribosome in regulating its function through post-
translational modification. Finally, we have a wealth of preliminary data linking RNA-quality control processes
with DNA repair. Aim 3 establishing molecular details about how signaling is transduced between the two
processes, which is hitherto unexplored. Altogether, we will leverage our expertise in ribosome biochemistry and
yeast genetics in combination with resources we accrued over the past funding period to reveal how collided
ribosomes provide a structural platform for several conserved signaling processes.

Public health relevance
NARRATIVE Cells employ multiple strategies, including transcriptional and posttranscriptional regulation events, to ensure that the correct protein is made at the right time and place. Failure to do so could result in drastic consequences such as cancer and cell death. This proposal addresses the mechanisms by which protein synthesis is regulated to maintain control over gene expression, which in turn could be used to develop therapeutics aimed at dealing with defects in the translation apparatus.